Strategies towards the Synthesis of Azetidine-Containing Metabolites Produced by Pseudomonas aeruginosa

Project Summary/Abstract
Total syntheses of novel azetidine-containing metabolites (azetidomonamide A, azetidopyridone, and
diazetidomonapyridone) from Pseudomonas aeruginosa do not exist, and are sorely needed so their biological
functions in quorum-sensing behavior can be evaluated. In particular, the exact mode of their production from
the non-ribosomal peptide synthetase (NRPS) enzymatic cluster is unknown; furthermore, elucidating the exact
role of these metabolites in modulating quorum-sensing behavior in P. aeruginosa is not currently possible due
to the minute quantities of metabolites produced in the natural bacterial system. Additionally, these metabolites
affect overall bacterial biofilm formation and the production of redox-active metabolites, which are partially
implicated in adverse outcomes for cystic fibrosis patients infected with P. aeruginosa. Thus, total syntheses of
these metabolites are highly needed and will have a broader impact on human health through expanding our
understanding of biofilm formation by P. aeruginosa, and potentially allowing for development of anti-virulence
treatments for it in the long term.
The studies described in this proposal seek to develop strategies for synthesis of these novel azetidine-
containing metabolites. Importantly, we propose orthogonal approaches that mitigate the risk of the overall goal
while still pushing chemical boundaries by leveraging modern chemistry in complex contexts. For the synthesis
of azetidomonamide A (Aim1), our design involves accessing and employing a unique ynamide cascade to
cyclize the system; a second approach utilizes enzymatic biocatalysis to install the alcohol stereocenter.
For the synthesis of diazetidomonapyridone (Aim 2), we first propose strategies for accessing the
azetidopyridone precursor. The initial approach would build on existing chemistry by utilizing a Pd-catalyzed
cascade cyclization with CO in a complex setting; an alternative approach alleviates the risk of the former
approach by employing condensation reactivity to install the requisite cyclic system. To access
diazetidomonapyridone from the azetidopyridone, we envision two approaches. The first employs a biomimetic
reflection of literature precedent by directly subjecting azetidopyridone to azetidomonamide A, which undergo
spontaneous reaction under basic conditions to access the target metabolite. Additionally, we propose accessing
diazetidomonapyridone via a bio-inspired approach that leverages ring formation to control alkene geometry.
Overall, the proposed research is significant because it provides creative strategies to establish the first
total syntheses of azetidomonamide A, azetidopyridone, which will enable their biological study. More broadly,
these strategies can be used to access similar scaffolds in other bacterial metabolites that have yet to be
synthesized. Performing this research in Prof. Reisman’s group at Caltech aligns well with their current success
in the efficient total synthesis of complex natural products and will augment my prior training in organometallic
chemistry to prepare me for a future academic career as a professor.

Public health relevance
Project Narrative The azetidine-containing metabolites azetidomonamide A, azetidopyridone, and diazetidomonapyridone have attracted recent interest due to their significance in biofilm and pigment production of the pathogenic bacterium Pseudomonas aeruginosa. Biological studies to understand the metabolites’ role in these bacterial quorum- sensing pathways have been hindered because the molecules are difficult to synthesize in significant quantities; this proposal seeks to establish their first chemical total syntheses. This project is relevant to the NIH’s mission because 1) in the short-term, it will expand current fundamental understanding in the synthesis of bioactive natural products, and 2) in the long-term, findings derived from biological studies of these metabolites could potentially lead to new anti-virulence treatments for those infected with P. aeruginosa.